Multimodal immune profiling to determine mechanisms of COVID-19 clinical trajectory in Uganda

PROJECT SUMMARY
The COVID-19 pandemic is the greatest global health crisis in over a century. In high-income countries (HICs),
outcomes for patients with severe COVID-19 have improved markedly over the past 18 months due to provision
of high-quality critical care and administration of immunomodulatory agents such as corticosteroids and
interleukin-6 antagonists. Effective use of these therapeutic agents was driven by translational investigations
that identified dysregulated immune-inflammatory responses as key pathological features in severe COVID-19.
Following advances in COVID-19 prevention in HICs, the pandemic burden has shifted to low- and middle-
income countries, which now account for >40% of daily mortality related to COVID-19. This burden is particularly
severe in sub-Saharan Africa (SSA), where recurrent COVID-19 surges have overwhelmed fragile health
systems and case fatality rates are among the highest in the world. Although the immunological context of
COVID-19 in SSA is unique due to high HIV burden and the relatively young age of hospitalized adults, among
other factors, little is known about the immunopathology of severe COVID-19 in the region. Through an
established collaboration between Columbia University and Uganda Virus Research Institute, we have
prospectively enrolled over 400 patients with COVID-19 in Uganda across the entire spectrum of illness severity.
Leveraging this unique cohort, the overall goal of this study is to determine biological mechanisms of COVID-19
clinical severity in Uganda using a multimodal approach to host immune profiling. We will determine the
relationship between soluble immune biomarkers and severe-critical illness among adults with COVID-19 in
Uganda using minimally-biased machine learning methods (Aim 1); identify biological pathways and immune cell
profiles associated with severe-critical COVID-19 in Uganda using whole-blood RNA sequencing data (Aim 2);
and integrate biomarker and RNA-sequencing data to determine the effect of HIV-infection on innate and
adaptive immune responses in COVID-19 (Aim 3). Directly addressing NIH COVID-19 research priorities, our
results will (i) advance fundamental understanding of the immunopathological mechanisms driving the burden of
severe COVID-19 in SSA and other vulnerable, high HIV burden settings, and (ii) classify patients with COVID-
19 into biologically-driven and clinically-meaningful subgroups for whom locally-responsive treatment strategies
can be more precisely investigated and developed.

Public health relevance
PROJECT NARRATIVE The global burden of severe COVID-19 is increasingly concentrated in sub-Saharan Africa (SSA), where recurrent case surges have overwhelmed fragile health systems and case fatality rates are among the highest in the world. This research will advance fundamental understanding of the immunological mechanisms of severe COVID-19 in sub-Saharan Africa, ultimately classifying patients with COVID-19 into biologically-driven subgroups for whom locally-responsive treatment strategies can be more precisely developed.